Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM – PROJECT SUMMARY
The goal of the Mayo Clinic HBCs SPORE Developmental Research Program (DRP) is to attract, develop,
support, and monitor the most promising and innovative projects pertaining to translational hepatobiliary cancer
research. Each year the DRP will provide three, one-year awards of $50,000 each with the possibility of an
additional year of support based upon the demonstration of significant progress and potential. A rigorous peer-
review process utilizing the expertise of the Internal Scientific Advisory Committee and other experienced
investigators will evaluate all applications based upon the following criteria: scientific merit, originality,
qualifications of the applicant/co-investigator(s), and translational potential. While the translational trajectory of
all applications needs to be readily apparent, we encourage high risk/high payoff proposals investigating all
aspects pertaining to the morbidity and mortality of hepatobiliary cancer from the bench to the population. This
will be accomplished through the following Specific Aims: (1) Solicit and support innovative and
interdisciplinary translationally-relevant laboratory, population science, and clinical studies in hepatobiliary
cancer; (2) Encourage the recruitment of qualified minorities, women, and persons with disabilities; (3) Provide
critical evaluation of all DRP applications and awardee progress; and (4) Facilitate the development of DRP
funded proposals into R01-level applications and/or future HBCs SPORE projects. It is expected that
developmental research project support will result in the generation of data that will serve as the basis for
additional HBCs SPORE-sponsored projects or support through other external peer-reviewed mechanisms.
The HBCs SPORE leadership will work with the investigators to help secure independent R01-level funding.
One-page outlines of three potential research projects are included to demonstrate the depth and breadth of
ongoing research that can be eligible for funding through the HBCs SPORE Developmental Research
Program.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM – PROJECT NARRATIVE The Developmental Research Program (DRP) is an important resource to support innovative translational research in hepatobiliary cancer. A rigorous process ensures transparency and fair review of applications. The DRP encourages inter-disciplinary proposals so as to rapidly translate new treatment concepts to patients.